Targeting Lipid Metabolism in the Tumor Microenvironment

Project Summary – Project 1

Our previous data have shown that the aged microenvironment drives resistance to targeted therapy, and
may impact response to immunotherapy as well. Tumor cells undergo metabolic reprogramming in order to
acquire resistance to BRAF/MEK inhibitors. We have found that one of the contributing factors to this
resistance may be lipids. Aged or stressed fibroblasts secrete lipids, which are taken up by melanoma cells,
promoting their ability to invade, and resist targeted therapy. These stromally-­induced changes can also
affect immune cells. Dendritic cells (DC) are required for the initiation and maintenance of immune
responses and lipid accumulation in DC decreases their ability to act as antigen presenting cells. Myeloid
derived suppressor cells (MDSCs) play a major role in regulation of antitumor immunity. These cells thrive on
lipid metabolism and they accumulate and use oxidized lipids to augment their ability to suppress the immune
microenvironment. We have implicated fatty acid (FA) transporter protein 2 (FATP2) in lipid accumulation by
both tumor cells and PMN-­MDSC, suggesting a complex crosstalk between multiple components of the TME.
We propose to identify the mechanism and subsequent functional consequences of lipid accumulation in
tumor cells and MDSCs. We will evaluate the effect of therapeutic targeting of lipid accumulation in MDSCs
on the generation of immune responses in melanoma models, and on tumor cell fate and response to
targeted therapy.

Public health relevance
Project Narrative – Project 1 The prognosis for melanoma patients over the age of 60 is markedly lower than younger patients, and therapy is less effective. We have discovered that aged fibroblasts secrete lipids that affect melanoma cell response to therapy, as well as the activity of myeloid derived suppressor cells. In this project, we will elucidate the mechanisms by which this occurs, and determine the implications of lipid accumulation in the aged tumor microenvironment for therapy of melanoma.